The CORAL Training Core

ABSTRACT - CORAL Training Core
Ending the maternal behavioral health crisis among Black women requires developing a new generation of
scientists, evidence, and interventions that (1) bridges historically siloed approaches to behavioral health and
maternal health, and (2) is authentically community engaged. Developing this new generation of scientists,
evidence, and interventions requires a paradigm shift in how we train and who we train as research
investigators and as knowledge producers. It requires a transdisciplinary approach to identifying and
intervening in the multilayered factors that that shape maternal behavioral health conditions among Black
women, and demands effective training in ethically engaging communities for just knowledge production and
impactful translation. The CORAL Training Core is designed to develop this new generation of scientists,
evidence, and interventions that will help end the maternal behavioral health crisis among Black women. It will
serve a pivotal role in promoting community-engaged research, developing early-stage investigators (ESIs),
and building transdisciplinary research capacity at the intersection of maternal health and behavioral health
with a focus on Black pregnant and postpartum women. It will leverage unique strengths of CORAL’s
Community Partnership Core and established relationships across Morehouse School of Medicine, Emory
University, and community partners to weave a focus on ethical community-engaged research into its
approach to: (1) Provide mentoring and career development for ESIs, with a particular focus on URM ESIs; (2)
Build research capacity among ESIs and established investigators for effective, ethical, community-engaged
research and dissemination; (3) Develop and administer a CORAL Project Program to provide >$520,000 in
research funding – most leveraged via in-kind support - for ESI, particularly URMs, to support their career
development in maternal behavioral health research and interventions with Black pregnant/ postpartum
women; and (4) Enhance collaboration with non-academic partners and other Centers of Excellence. The
Training Core will be co-led by two faculty with complementary training, experience, and expertise: Dr. Dawn
Tyus, Project Director and Principal Investigator for the African American Behavioral Health Center of
Excellence at Morehouse School of Medicine, and Dr. Michael Kramer, Director of the Maternal and Child
Health Center of Excellence at Emory Rollins School of Public Health. By achieving its aims, CORAL’s Training
Core will develop the next generation of transdisciplinary, community-engaged scientists, evidence, and
interventions needed to end the maternal behavioral health crisis among Black women.